Developing a comprehensive model for peripheral nerve stimulation of gastrointestinal function

SUMMARY
One in five people suffer from some form of functional gastrointestinal and motility disorders (FGIMD), a group
of diseases caused by malfunction of the enteric (gut) nervous system (ENS), including irritable bowel syndrome,
fecal incontinence, constipation, dyspepsia, and others. Pharmaceutical intervention is largely unsuccessful at
managing these conditions. Recently, electrical sacral nerve stimulation (SNS) has emerged as an alternative
therapy for FGIMD. However, how the sacral nerves innervate and modulate the ENS is unknown, so clinicians
have to resort to one set of empirical stimulation parameters in hopes of relieving different (sometimes opposite)
conditions, with very inconsistent outcomes.
The objective of this project is to understanding how the sacral nerves innervate and modulate the enteric
nervous system. We pose three hypothetical mechanisms through which SNS modulates gut motility: SNS
modulates [a] enteric neurons, [b] smooth muscle, and / or [c] intrinsic pacemaker cells. The challenge is that
there is no specific tool, such as pharmacological blockers, transgenic animal models, etc., that can distinguish
these three hypothetical mechanisms in vivo.
To overcome this challenge, we will build the first computational model that integrates the sacral nerves, the
ENS, and GI motility. For each hypothetic mechanism, the in silico framework will predict distinct neuron and
muscle firing patterns, which can then be experimentally validated in vivo by c-Fos+ immunomapping and
intravital colon imaging. The in silico framework will also predict motility patterns during SNS, which will be
validated by implantable motility sensors in awake animals. Once the fundamental mechanism of the SNS-ENS
interface is understood, we will use the improved in silico model to optimize SNS parameters that maximally
increase or decrease colonic motility, followed by in vivo validation.
In summary, we will combine computational modeling and in vivo experiments to determine how the sacral
nerves innervate and modulate the ENS and GI motility. Our model will provide fundamental understanding of
how peripheral nerves interface with an organ, which is generalizable to other types of peripheral nerves such
as the vagus nerve. The model will also enable us to test the hypothesis that specific stimulation patterns can
be delivered to treat different conditions in the lower GI system, rather than using the current one-size-fits-all,
hit-or-miss approach.

Public health relevance
PROJECT NARRATIVE One in five people suffer from some form of functional gastrointestinal and motility disorders (FGIMD). The objective of this project is to build and validate a computational model of the sacral nerve modulation of the enteric nervous system and gut motility. The model will be essential for understanding the fundamental mechanism of sacral innervation of the gut and provide a framework for identifying stimulation parameters to treat dysmotility in the gut.